Cell intrinsic antiviral immunity in diverse bats

Project Summary
Bats serve as reservoirs for numerous viruses that spill over to humans and cause disease. The immune
adaptations that allow bats to control viral infections without developing disease are not clearly defined. This
project aims to investigate cell-intrinsic antiviral mechanisms in bats, focusing on interferon-stimulated
genes (ISGs) and their evolutionary adaptations. We will examine the antiviral properties of RTP4, a rapidly
evolving RNA-binding protein that inhibits flaviviruses, which have been associated with bats for decades
but are relatively understudied compared to other viral zoonoses. Through biochemical, genetic, virological,
and cell biological approaches, we will determine the antiviral molecular mechanism of RTP4 and assess
the functional diversity of ISGs across multiple bat species. Successful completion of this project will
significantly advance our understanding of bat immunity by defining the molecular mechanisms underlying a
bat-flavivirus arms race, and by expanding the known repertoire of antiviral bat ISGs. These outcomes will
set the stage for future mechanistic studies and may inform strategies to combat zoonotic disease.

Public health relevance
Project Narrative Understanding how bats control viral infections without developing disease can provide critical insights into immune regulation and antiviral defense mechanisms. This research aims to uncover the molecular mechanisms of bat interferon-stimulated genes and their role in controlling viral infections. These findings may inform future strategies for preventing and mitigating zoonotic diseases in humans.